Contribution of Longitudinal Neighborhood Determinants to Cognitive Health and Dementia Disparities within a Multi-Ethnic Cohort

PROJECT SUMMARY/ABSTRACT
Beyond the role that individual factors (e.g. age, race, gender, and socioeconomic status) play in the
progression of Alzheimer's Disease and related dementias (ADRD), neighborhood factors (e.g. social and built
environments) may affect cognitive health. Critically, although African American and Hispanic individuals face
the highest and most disproportionate risk for ADRD, research has traditionally excluded diverse populations.
Given historic and current patterning of healthy neighborhood factors by racial and socioeconomic
characteristics, these features may partially explain observed disparities in ADRD risk. To date there has been
no research on the role of neighborhood environments in disparities in ADRD risk.
In this study, we propose to leverage and extend extensive longitudinal data from the Multi-Ethnic Study of
Atherosclerosis (MESA) to address major gaps in research on neighborhoods and disparities in ADRD. We
propose to undertake large-scale collection, processing, and distribution of new neighborhood data within
MESA. Our main objective is to identify unique patterns of neighborhood change related to the causes of
prevalence and disparities in cognitive decline and dementia. We will attain our main objective by (Aim 1)
characterizing dynamic, longitudinal neighborhood social and built environment variables (survey-based and
GIS-derived) relevant to cognition for residential addresses of a MESA; (Aim 2) examining associations of
neighborhood environmental characteristics with cognition and clinically relevant ADRD outcomes; (Aim 3)
investigate determinants of disparities in ADRD outcomes by socioeconomic position and race/ethnicity and
assess the contribution of neighborhood environments.
This project is poised to provide robust new evidence about pathways and links between neighborhood
environments and cognitive outcomes, with important implications for built environment science, ADRD
progression research, and policies to support healthy aging. Aim 1 will create the most comprehensive
longitudinal neighborhood dataset on a diverse sample with detailed cognitive and ADRD outcomes for
widespread dissemination to a network of researchers. Analyses in Aim 2 will contribute to developing
substantive theory on the role of neighborhoods in ADRD progression and provide guidance for urban planners
to design neighborhoods that support healthy aging. Aim 3 examines component contributions to racial
disparities in cognition and ADRD. Through this, we expect to identify actionable, community and clinical
interventions to address and remediate racial and socioeconomic inequalities derived from the unequal
distribution of environmental supports for healthy aging. We expect this evidence to support and amplify efforts
to reduce disparities.

Public health relevance
PROJECT NARRATIVE The burden of Alzheimer's disease and related dementias (ADRD) is increasing nationally and globally, with disproportionate impacts on lower-income, lower-education, and minority race/ethnic older adults. Presence of and inequalities in neighborhood factors (e.g. social context or physical and built environments) may affect cognitive decline and be key for intervening on ADRD risk and disparities at the population level. In this study, researchers collect, process, and link extensive neighborhood data to the Multi-Ethnic Study of Atherosclerosis (MESA), creating an unprecedented 25+ year dataset that can expand evidence on the role of residential contexts in impacting comprehensive cognitive health outcomes within a national, multi-ethnic cohort.